Image Deeper with Synthetic Waves: A Novel Non-Invasive Optical Approach for Skin Lesion Assessment at Multiple Scales

ABSTRACT
Optical imaging techniques have revolutionized medical care due to their high sensitivity, safety, affordability,
and ability to assess both structure and function in accessible tissues (e.g., vascular intima, oral cavity
epithelium) and transparent organs (e.g., the eye). Despite significant advances over the past decades, imaging
deep clinically relevant structures within highly scattering tissue remains a challenge. These limitations are
particularly evident in imaging of skin cancer—the most prevalent malignancy worldwide. Current imaging
systems are typically limited to very narrow specifications, restricting their adaptability to image a wide range of
skin lesions at different depths. Optical methods using visible to near infrared wavelengths (such as confocal
microscopy or optical coherence tomography) offer superior contrast and resolution at shallow tissue depths.
However, their short wavelengths (<1.5μm) result in high scattering, making them inadequate for critical “deep”
applications such as assessing tumor invasion and treatment response. Acoustic “long wavelength” approaches
like ultrasound imaging provide an alternative to image deeper layers, although at lower resolution. Moreover,
the physical properties of the acoustic wave typically yield insufficient contrast for effective skin cancer imaging.
Similarly, hybrid approaches such as photoacoustic imaging primarily only detect absorption changes, limiting
tumor visualization to unreliable vascular alterations, melanin presence, or exogenous contrast agent uptake.
To overcome these limitations, we propose the novel Synthetic Wavelength Imaging (SWI) to visualize non-
melanoma skin cancers (NMSC) at a wide range of depth. By mixing two captured optical fields, SWI generates
a "long" synthetic beat wave carried by optical waves. This long synthetic wave makes the approach robust to
scattering while preserving the high contrast of the optical carrier wavelengths, enabling high-resolution imaging
of small structures within the synthetic wave’s near field. With SWI we aim to break the conventional resolution-
depth-contrast tradeoff. Our system will enable the fast (a few ms) measurements of subtle tissue changes in
NMSC at significantly greater depths than existing optical imaging methods while offering high resolution and
greater contrast than long-wave or hybrid approaches. This advancement will facilitate the first clinical
demonstration of SWI in the critical, unmet need of NMSC assessment. Furthermore, SWI’s wide tunability
enables future multi-scale imaging for applications such as brain vasculature or tumor assessment.
Our objective is to develop the first clinical implementation of SWI and evaluate its performance for NMSC
characterization. We hypothesize that our non-invasive imaging system will overcome existing limitations,
addressing the pressing need for improved skin cancer imaging across tumors of varying sizes and depths during
therapeutic interventions and surveillance. To test this hypothesis, we will pursue three specific aims:
1) technology development, 2) imaging models of normal skin and NMSC, and 3) human pilot testing.

Public health relevance
PROJECT NARRATIVE Biomedical imaging techniques have revolutionized disease diagnosis, treatment, and monitoring, yet they often face a trade-off between imaging depth, resolution, and contrast. We propose a novel approach, synthetic wavelength imaging, that leverages the combination of multiple optical wavelengths to achieve simultaneous high depth, resolution, and contrast. While this versatile technique has broad applications, as a first demonstration we will apply it to non-melanoma skin cancer, a highly prevalent disease worldwide with pressing need for better imaging to enable optimal management.